Graphene-based Nanosensor Device for Rapid, Onsite Detection of Total Lead in Tap Water

PROJECT SUMMARY
Aging water infrastructure across the United States still contains significant amounts of components that
contain lead. There are many old service lines in use that are made of lead and other components, such as
elbows and solder, containing some lead that leeches into the drinking water. The negative health impacts of
lead are primarily attributed to chronic exposure to sources with undetected lead, which are particularly
troublesome and problematic because of the neurological damage to children. Current lead testing methods are
either accurate, expensive, slow, and difficult; or low-cost, fast, easy to use, and notoriously inaccurate. The
frequency of current testing is inadequate. The regular use of the NanoAffix Science, LLC (NAFX) handheld lead
tester - even if intermittently - will virtually eliminate the chance of chronic exposure to undetected lead, thereby
accruing significant and predictable public health impact, especially in those locations that are at the highest
risk.
NAFX proposes to address the above unmet need by increasing access to quantitative water quality
monitoring with a low-cost, easy-to-use, and accurate handheld lead test kit for rapid detection of total lead in
drinking water. The handheld lead testing kit combines a novel proprietary sensor chip with nanoscale thin film
coatings in a proprietary test cell with a portable meter that communicates via Bluetooth with a smartphone app
for direct readout of testing results. The Phase II project successfully developed a minimum viable product that
has led to some initial sales orders by early adopters and potential business partners. A proprietary and novel
solution for dissolving particulate lead was developed and market research was conducted through a beta-testing
program using prototype devices. NAFX successfully transitioned from lab scale production to pilot scale
production.
As part of the commercial readiness pilot (CRP) program, NAFX will scale up manufacturing beyond pilot
scale, conduct additional product development based on the feedback received from initial customers and the
field validation conducted as part of the beta-testing program. Product and method certifications will be obtained
to ensure that customers who test for regulatory compliance purposes are able to use the NAFX product. Scaling
up manufacturing will lead to reduced variability, reduced costs, and the ability of NAFX to fulfill larger orders.
NAFX will continue to engage in market planning and research to better understand our current target markets
and to learn of new target markets.

Public health relevance
PROJECT NARRATIVE The NanoAffix Science, LLC Commercialization Readiness Pilot (CRP) Program project aims to continue the development of a handheld lead tester for accurate and low-cost onsite detection of total lead in drinking water by non-technical experts, based on the success of the Phase II project. The project will further NanoAffix’s mission to increase the accessibility of quantitative water quality monitoring with strategic development and refinement of the product. NanoAffix will continue product development to improve performance and ease of use, scale up manufacturing beyond pilot scale production, obtain product and method certifications from relevant organizations, and engage in market research and planning to better understand our target markets.